Establishing the role of Dual-Specificity Tyrosine Phosphorylation-Regulated Kinase 1A trisomy in juvenile plasticity impairment in Down Syndrome

An understanding of the genetic and molecular bases for developmental delay in Down syndrome (DS) will be
critical for the design of strategies to improve cognitive function in DS; however, a fundamental gap exists in our
knowledge of the effects of trisomy on juvenile cortical development when activity sculpts the functional circuitry
of the brain. The mouse visual system affords a novel window into this process with robust, activity-dependent
behaviors that can be elicited in a well-characterized, neural circuit. Ts65Dn mice, a well-studied model of DS,
demonstrate a defect in ocular dominance plasticity (ODP), a juvenile visual cortical response to loss of input
from one eye that in normal mice results in strengthening of cortical responses to stimulation of the nondeprived
eye. Ts1Rhr mice harbor a smaller duplication and demonstrate similar plasticity impairment. Within the Ts1Rhr
duplication, preliminary data indicate that the gene encoding Dual-specificity tyrosine phosphorylation-regulated
kinase 1a (DYRK1A) drives impairment when trisomic and this impairment can be rescued by restoration of
Dyrk1a disomy. Dyrk1a haploinsufficiency also impairs ODP, suggesting that too little DYRK1A activity can be
as deleterious as too much activity; identifying DYRK1A effectors may provide additional, potentially safer, drug
targets as well as reveal the underlying mechanism of DYRK1A-driven impairment. In vitro studies have impli-
cated DYRK1A in hippocampal plasticity impairment and in behavioral phenotypes, though the mechanisms
underlying these phenotypes are not well understood. The central hypothesis is that Dyrk1a trisomy causes
aberrant kinase activity that disrupts neuronal function and consequently impairs cortical circuit function during
juvenile development in DS. The experiments of Aim 1 explore the extent to which Dyrk1a trisomy can account
for impairment in the context of model mice with a larger complement of trisomic genes (Dp1Yey mice; Aim 1a),
and whether postnatal, pharmacologic inhibition of DYRK1A can restore ODP in Ts1Rhr mice (Aim 1b) using
awake optical imaging of intrinsic signals and immediate early gene expression to measure cortical responses
to visual stimulation. Aim 2 focuses on the cellular and molecular bases for circuit impairment in Dyrk1a trisomic
mice. The Cre-Lox recombination system will be used to assess whether Dyrk1a trisomy is required in excitatory
or in inhibitory neurons to impair ODP in Ts1Rhr mice (Aim 2a). The cellular and physiologic effects of Dyrk1a
trisomy will be assessed through patch clamp electrophysiologic analysis of L4 principal neurons, the primary
cortical neurons that receive input from both eyes (Aim 2b). To identify DYRK1A effectors, laser capture micros-
copy will be coupled with mass spectrometry to perform phosphoproteomic analysis of visual cortical layer 4 in
Ts1Rhr mice with 2 or with 3 copies of Dyrk1A in the presence or absence of a challenge of loss of vision in one
eye (Aim 2c). The proposed experiments will address fundamental questions and open new avenues of inquiry
critical to the design and implementation of therapies to ameliorate developmental delay and intellectual disability
in people with DS.

Public health relevance
Project Narrative The proposed research is relevant to public health because this work will provide a new perspective on the molecular pathogenesis of Down syndrome (DS), the most common genetic cause of intellectual disability, which will enable the identification of new drug targets and provide an approach to test candidate therapies to prevent developmental delay and cognitive impairment in individuals with DS. The proposed research is relevant to the NIH’s mission “to seek fundamental knowledge about the nature and behavior of living systems and the applica- tion of that knowledge to enhance health, lengthen life, and reduce illness and disability.” This work will also help to achieve goals of the NIH INvestigation of Co-occurring conditions across the Lifespan to Understand Down syndrome (INCLUDE) Project to “improve understanding of the biology of Down syndrome and support development of new treatments for health conditions experienced by individuals with Down syndrome.”